The effect of age-related changes in macrophage polarization and the post-injury immune response on fracture healing

Project Abstract
Aging is associated with an increased incidence of fracture, subsequent increased morbidity and mortality,
increased rates of nonunion and delayed bone healing. Aging is thought to result in an increased baseline
inflammatory state, known as “inflamm-aging”. Strategies to improve fracture healing in these patients must start
with a clear understanding of why fracture repair is inhibited with age so targeted interventions can be developed.
Fracture triggers a robust inflammatory response to initiate healing. Following this initial inflammatory phase, an
anti-inflammatory response is initiated that drives tissue regeneration. Disruption of this transition may result in
decreased fracture healing. Macrophages are thought to play a vital role in this process, with classically activated
(M1) macrophages driving early inflammation, followed by a transition to an anti-inflammatory alternatively
activated (M2) macrophage response. Aging is associated with an increased baseline inflammatory state, known
as “inflamm-aging”. This imbalance may drive the delayed healing observed in geriatric fracture patients.
However, work in human subject has been minimal, and the role of aging in fracture healing remains a poorly
understood area of study.
We hypothesize that this imbalance drives the impaired geriatric fracture healing response and expect that
elderly patients have an increased initial inflammatory response at the time of fracture with a decreased ability
to mount the subsequent anti-inflammatory response required for initiation of the regenerative phase of fracture
healing and derangements in macrophage polarization. Two primary aims well assist in quantifying the
differences in the fracture microenvironments between young and elderly patients.
AIM1: To determine if geriatric fracture patients have altered macrophage polarization and an increased
inflammatory response at the site of acute fracture compared to younger individuals.
AIM2: to determine if geriatric fracture patients have an altered transition to M2 polarization and a delay
in the production of anti-inflammatory cytokines at the fracture site during fracture healing compared to
younger individuals.
This innovative study would be the first to critically examine the role of macrophage polarization in human
subjects, bridging the gap between animal and human models and identifying potential therapeutic targets for
further study.

Public health relevance
Project Narrative This study aims to elucidate age-related differences in the fracture microenvironment in geriatric patients, addressing a critical gap in understanding delayed fracture healing in the elderly. Findings will provide fundamental insights into the inflammatory and healing processes affected by aging, which are essential for developing age-targeted therapeutic interventions. This research has the potential to improve clinical outcomes, reduce morbidity, identify therapeutic targets for further research, and enhance quality of life for elderly individuals suffering from fractures.